Investigating the Role of MYH14 in Tension-Dependent Cardiomyocyte Hypertrophy

PROJECT SUMMARY / ABSTRACT
Heart failure is a leading cause of hospitalization and a primary driver behind rising healthcare costs. Using a
systems genetics approach in mice, we have previously identified a non-muscle myosin encoded by the gene
Myh14 as a genetic modifier of heart failure. Using a genetically modified Myh14 knockout mouse model, we
have further validated its importance in the maintenance of cardiac homeostasis through ongoing NIH K08
supported research. As a part of the K08 award, we have determined the subcellular localization of MYH14 in
murine heart tissue and neonatal rat ventricular cell culture. However, its specific roles in maintenance of
cardiac homeostasis remains elusive.
MYH14, also known as non-muscle myosin II-C (NMIIC), is the newest member of the non-muscle myosin II
family of ATP-dependent molecular motors. MYH14 is an established causal gene for hereditary hearing loss
and is believed to be the master integrators of force within epithelial apical junctions, mediating epithelial tissue
morphogenesis and tensional homeostasis. Recently, the R941L mutation in MYH14 was demonstrated to act
in a dominant-negative fashion to inhibit mitochondrial fission, especially in the cell periphery, and to alter the
organization of the mitochondrial genome in patient fibroblast lines. In addition to localization in the intercalated
disc, as shown in prior literature, we found that MYH14 is expressed at or near the costameres. We
hypothesize that MYH14 may be key player in modulating the heart’s adaptive response to mechanical stress.
This R03 proposal describes a 2-year plan to detail MYH14’s subsarcolemmal and cytoplasmic localization,
relationships with the other known non-muscle myosin in cardiomyocyte, MYH10, response to hormonal
signals and physical interactors. Fundamental understanding of MYH14’s function in the cardiomyocytes will
provide insights into how the cardiomyocyte responds to mechanical stress as well as hormonal signals that
may modulate this response. Moreover, these insights will allow us to predict outcomes when such
homeostatic mechanisms break down in different forms of cardiac pathologies. Finally, insights from this study
may shed light how such homeostatic system may be nudge to promote health versus disease.

Public health relevance
PROJECT NARRATIVE We have identified MYH14, a contractile molecular motor, as a novel protein that modulates the heart’s adaptive responses to mechanical stress. The proposed study aims to investigate the roles that MYH14 plays inside heart cells using super-resolution microscopy, stimulation with mechanical and hormonal cues and identifying interacting proteins. Insights on MYH14’s function in the heart may lead to improved understanding of how the heart handles mechanical and hormonal stressors and ways to intervene when such protective mechanisms break down.